Investigating stochastic genome folding as a mechanism to generate cell-surface protein diversity required for neural self-avoidance

PROJECT SUMMARY
During brain development, the assembly of functional neural circuits necessitates sophisticated regulation of
neural arborization patterns. This mechanism is achieved by a process known as neural self-avoidance, which
allows projections from the same neuron to recognize and avoid self. In mammals, the regulation of neural self-
avoidance relies on the expression of distinct repertoires of clustered Protocadherin (Pcdh) cell-surface protein
isoforms in individual neurons. Neural-type-specific Pcdh expression is provided by a remarkable and complex
mechanism of promoter selection, wherein individual neurons can choose which and how many of the 120 Pcdh
isoforms (60 on each of the two parental chromosomes) to express and thereby acquire specific instructions for
their connectivity patterns. For instance, convergence of olfactory sensory neuron (OSN) projections requires
random expression of distinct Pcdh isoforms in individual cells, while tiling of neural arbors of serotonergic
neurons (5-HTs) requires expression of the same isoform. Despite the fundamental role that Pcdh genes play in
sculpting neural circuits and their implication in several devastating neurological and neuropsychiatric disorders,
the molecular strategy by which individual neurons express unique combinations of Pcdh genes remains a
mystery. Here we propose to investigate the mechanism of Pcdh gene choice in vivo using mouse olfactory
sensory neurons and their progenitor cells by the cohesin protein complex and its regulator WAPL. The proposed
studies rest on published and unpublished preliminary data that implicate cohesin in shaping the three-
dimensional architecture of the Pcdh locus and its expression regulation. Our findings will not only illuminate the
mechanisms of circuit assembly for olfactory sensory neurons, but they will also provide an unprecedented view
of neural patterning across scales, linking cell-type-specific regulation of cohesin to neural wiring during brain
development. Finally, we anticipate that our findings will also generate new hypotheses for how chromosome
architecture governs gene expression more broadly.

Public health relevance
PROJECT NARRATIVE The purpose of this research proposal is to uncover the functional link between nuclear architecture and brain architecture governed by clustered Protocadherin (Pcdh) genes using mouse olfactory sensory neurons as model system. As Pcdh proteins play an essential role in brain wiring and as dysregulation of their expression is implicated in several neurological disorders, understanding how these genes are expressed in the mammalian brain has direct relevance to human health and disease.